Circuit-specific plasticity mechanisms for habitual behavior

Abstract
The ability to learn which action strategies produce positive outcomes is a central process for adaptive behaviors.
Through repetition, action strategies naturally evolve from a flexible (goal-directed) phase into an automatic
(habitual) phase. The dorsal striatum is required for the transition between goal-directed and habitual action
strategies. Studies over the past two decades have demonstrated that dorsomedial striatum (DMS) is required
for goal behavior whereas the dorsolateral striatum (DLS) is required for habitual behavior. Numerous studies
have associated long-lasting modifications of DLS circuitry with habitual behavior, but all these plasticity
observations were from bulk stimulation of unidentified cortical inputs to striatum. Therefore, it is unknown which
cortical inputs to striatum undergo long-lasting modifications over the course of habit formation nor the role these
plasticity sites play in habit expression. This project employs two unique strategies to fill this gap. First, we will
genetically isolate the two major types of cortical inputs to striatum, the pyramidal tract (PT) and
intratelencephalic tract (IT). PT circuits are selectively active during movement; therefore, it is possible long-term
modifications of PT circuits sustain motor output for habit expression. Second, we will identify novel cortical
regions whose activity is modulated by behavioral transitioning from goal to habit states using Fos-TRAP2
technology. Aim 1 will test the hypothesis that habit expression is accompanied by selective plasticity of PT
inputs, and not IT, using optogenetic approaches to activate and quantitatively measure the synaptic strength
(whole cell patch clamp and 2-photon imaging of GCaMPs) of PT and IT inputs to striatum in acute brain slices
from behaviorally defined mice. I will target orbitofrontal cortex (OFC) inputs to DMS and secondary motor cortex
(M2) input to DLS based on preliminary data and published studies suggesting habit is associated with
weakening of OFC circuits and strengthening of M2 circuits. Outcomes will provide the first measure of these
specific synapses in goal and habit states. Aim 2 will test the hypothesis that weakening OFC pyramidal tract
inputs to DMS speeds habit, whereas weakening M2 pyramidal tract inputs to DLS delays habit. I will test this
using cell specific pharmacology (DART technology) to dampen glutamatergic input to PT or IT cortical circuits
that innervate striatum, thus establishing causal contributions of defined corticostriatal circuits to the expression
of habitual behavior. Aim 3 will construct a state-dependent map of neuronal activity across cortical regions that
innervate DMS and DLS using molecular genetic capture of activity ensembles (Fos-TRAP2 technology) and
immuno-staining. Outcomes are expected to identify novel cortical regions associated with habitual behavior.
Collectively, completion of this proposal will identify circuit-specific plasticity mechanisms involved in habitual
behavior, producing a detailed plasticity model to better understand neural basis of adaptive habit formation and
how disruptions in this process may accompany numerous neuropsychiatric disorders.

Public health relevance
Project Narrative The ability to make new habits through experience is essential to successfully navigate familiar environments. Despite this, it is not fully understood which neural circuits change from experience, nor if these changes are necessary to make new habits. Here, we investigate these gaps in our understanding using electrophysiology, cell-specific pharmacology, and immunohistochemical approaches to detail novel sites of experience- dependent plasticity required for making new habits.